Nat. PETE HAZMAT Training Initiative at DOE Nuclear Weapons Complex

The Partnership for Environmental Technology Education (PETE) submits
this proposal on behalf of the Community College for Health and Safety Training
(CCCHST) serving Department of Energy (DOE) environmental restoration and waste
management sites at: Oak Ridge Operations, TN; Portsmouth Site, OH; Savannah River
Site, SC; Pantex, TX and Los Alamos National Laboratory, NM.
The intent of CCCHST-DOE is to provide convenient, consistent, memorable, and
cost-effective 29 CFR 1910.120 worker training to DOE contractors and subcontractors.
Workers gain the knowledge and skills to protect themselves and their communities
from exposure to hazardous materials during hazardous waste operations, facility
decommissioning and decontamination, hazardous materials transportation,
environmental restoration of contaminated facilities or chemical emergency response.
Over the five-year award, CCCHST members including Amarillo Community
College (TX), Roane State Community College (TN), Greenville Technical College (SC),
and Santa Fe Community College (NM) will train 17,500, workers, technicians and
supervisors, through 250,000 contact hours of training, to protect themselves, their
facilities, and their communities from exposure to hazardous materials encountered
during hazardous waste site clean-up, in the transportation of hazardous materials, and
in the response to releases of hazardous materials. Each year, 3,500 workers will
successfully complete 350 courses for a total 35,000 contact hours of raining. Annually,
an average 75 courses will be delivered online.
PETE will provide hazardous materials curriculum, developed by the Hazardous
Materials Training and Research Institute and adapted and maintained by PETE. PETE
will provide students online access to curriculum for 24 hours of the 40-hour
HazWoper, 12 hours of the 24-hour Emergency Spill Response and 8-hour Refreshers.
PETE will also support other DOE-approved curriculum requested by the DOE facilities.
PETE will provide centralized record keeping and quality control for the
consortium, submitting to the NIEHS data management system the number of students
trained at CCCHST-DOE sites and their demographic data, registering curricula with the
NIEHS Clearinghouse, providing technical assistance, conducting site audits, reviewing
student evaluations, acting upon the guidance of the advisory committee, and mediating
the delivery of training with other NIEHS-supported consortia.

Public health relevance
Narrative The Department of Energy and predecessor agencies have been involved in the research, production and testing of nuclear weapons since the 1940s. During that time, numerous facilities, both government and privately-owned, were constructed or leased across the country to support the effort, generating large quantities of radioactive and hazardous materials that resulted in the contamination of many of the facilities and surrounding areas. In 1994, to protect the staff and workers doing DOE cleanup and waste management work, legislation was enacted to allow the Department of Energy to fund NIEHS to develop Worker Training programs that would assure workers, other facility personnel, and community responders the knowledge and skills to protect themselves and their communities from hazardous conditions in the workplace. The Community College Consortium for Health and Safety Training (CCCHST) has been continuously supported by NIEHS since 1995 to provide quality training that is efficient, consistent, flexible, and cost-effective for the multiple tiers of contractors at DOE sites including the Oakridge complex, Portsmouth, Pantex, the Savannah River Site, and Los Alamos National Lab and in 2026 CCCHST will provide 3,500 students with 350 courses for a total 35,000 contact hours of training, with an average 75 courses delivered online.